COVID-19 Pandemic-related Changes in the Child Tax Credit and Effects on Behavioral Health for Medicaid-enrolled Adolescents

ABSTRACT
Adolescent behavioral health was already in crisis prior to the COVID-19 pandemic and has only worsened.
Pandemic-related changes to the 2021 Child Tax Credit (CTC) offered financial relief to disadvantaged
families. The changes were historic; the amount of refundable credit per child more than doubled, families with
no or very low income were no longer excluded, and half the credit was paid through advance monthly
payments (July-December 2021). Increased household income is a modifiable social determinant of health that
could improve adolescent mental health through reduced household stressors. We hypothesize that compared
to adolescents who were not age-eligible for the CTC, the additional CTC advance payments for age-eligible
adolescents will lower their risk for adverse behavioral health events. We also expect that the CTC provided
enabling resources for vulnerable adolescents with major depressive disorders (MDD) to continue treatment.
The goals of the proposed study are to examine the effects of the CTC advance payments on adolescent
behavioral health and treatment engagement through an innovative, quasi-experimental design (difference-in-
differences, DID) and concurrent mixed-methods approach. For Aim 1, DID will compare effects before,
during, and after the CTC advance payment period (1/2021-6/2021, 7/2021-12/2021, and 1/2022-9/2022) for
two age groups: 1) adolescents who turned 18 fourth quarter of 2021 (not eligible for 2021 CTC advance
payment), and 2) adolescents who turned 18 first quarter of 2022 (eligible). We will use two data sources to
conduct these analyses from a state and national perspective: 1) Ohio Medicaid ACO (n=10,521), and 2)
national Medicaid T-MSIS Analytic Files (n=972,000). Our Aim 1 outcomes include a) adverse behavioral
health events (deliberate self-harm, psychiatric crisis, alcohol/drug poisoning) in emergency
department/inpatient setting, and mortality (suicide, all-cause); and b) outpatient treatment and
pharmacotherapy continuation (among adolescents with MDD). For Aim 2, we will recruit adolescents with a
diagnosis of MDD and their caregivers using purposive sampling with quantitative Ohio Medicaid claims data
for qualitative interviews (n=90). Interviews will explore the influence of the CTC on family financial distress,
household resources, adolescent behavioral health and treatment engagement from diverse perspectives
(racial/ethnic minorities and rural residents). Finally, Aim 3 will explore heterogeneity of the CTC treatment
effects for racial/ethnic minorities and rural residents. The validity of our findings will be strengthened by using
multiple data sources and a concurrent mixed-methods approach, including diverse perspectives from
qualitative interviews and input from our stakeholder advisory group of national and state policy experts,
community-based service providers, adolescent behavioral health providers, and families with lived
experience. Impact. Our findings will have important implications for the effects of anti-poverty policies on
mental health among vulnerable adolescents and could point to solutions for a growing mental health crisis.

Public health relevance
PROJECT NARRATIVE Adolescents from socioeconomically disadvantaged families experience a high burden of adverse mental health outcomes, including a high risk for suicide, psychiatric crises, and drug overdose. Pandemic-related changes to the Child Tax Credit (CTC) were a lifeline at a time when many socioeconomically disadvantaged families were suffering and through alleviating family financial distress and providing critical resources, the CTC advance monthly payments introduced in 2021 had the potential to reduce the pandemic's adverse mental health effects. Through an innovative mixed-methods and quasi-experimental design, we will determine whether anti-poverty policies such as the CTC are effective tools for targeting modifiable social determinants of health and addressing the growing adolescent mental health crisis, which will inform future policy making.